Southern California Center for Chronic Health Disparities in Latino Children and Families.

Project Summary/Abstract
The prevalence of prediabetes and type 2 diabetes (T2D) among Latino adults in the United States is a
significant health concern. With T2D affecting approximately 15% of Latinos, accounting for about 10 million
individuals, there is a clear disparity compared to non-Hispanic Whites. The overarching goal of this innovative
intervention project is to enhance glycemic control in individuals with prediabetes and prevent the progression
to T2D among Latinos. This project aims to develop and evaluate a new intervention, called Mi Control!, which
combines continuous glucose monitoring (CGM) feedback using the latest non-invasive self-monitoring
technology with T2D prevention educational video clips. The intervention will specifically target the needs of
Latinos, based on information gathered from the experiences and feedback of Spanish- and/or English-
speaking Latino community health workers (Promotores) wearing CGM devices. The project consists of three
iterative studies to achieve its objectives: Study 1: This intervention development study will involve 20
Promotores de salud, who will wear a CGM sensor for 14 days. The sensor will provide real-time smartphone
visual and audio feedback on glycemic variability, and participants will maintain timestamped dietary records.
Video-recorded interviews will be conducted to capture the experiential narrative and explore the benefits,
barriers, and behavior changes related to the CGM device. Video clips will be selected and edited from these
interviews to create a series of smartphone-based educational clips for the intervention. An artificial intelligence
(AI) tool will be utilized for language translation. Study 2: This feasibility study aims to assess the impact of Mi
Control! on glycemic data capture and outcomes among an independent sample of 30 Promotores with
prediabetes. Participants will wear the CGM device for 14 days, and the study will include a control period
followed by a period with unmasked CGM glycemic feedback and smartphone text links to the Mi Control!
video clips. Measures of satisfaction with the CGM device and the intervention will be collected. The study will
evaluate the feasibility of Mi Control! augmented by the AI tool for language translation, and its impact on
glycemic control and knowledge retention among the Latino Promotores with confirmed prediabetes. Study 3:
This generality study aims to assess the effectiveness of Mi Control! on glycemic control and dietary behavior
among a community-based sample of 40 Latino parents with confirmed prediabetes. Participants will be
parents of children recruited from an ongoing cohort study of Latino families (Center Project 1). Participants will
experience the same study method as in Study 2 and glycemic control and dietary behavior during the masked
and unmasked phases will be compared. Overall, this project will contribute to the development of an
innovative intervention to improve prediabetes glycemic control and prevent T2D in the Latino population. By
utilizing emerging technologies, such as CGM and AI, and tailoring the intervention to the specific needs of
Latinos, this research aims to address the significant health disparities observed in this population.

Public health relevance
Project Narrative The prevalence of prediabetes and type 2 diabetes (T2D) among Latinos in the United States is a significant health concern. This innovative project aims to develop and evaluate Mi Control!, an intervention combining continuous glucose monitoring and T2D prevention educational video clips, to enhance glycemic control and prevent T2D progression in Latinos. The project will address health disparities and contribute to improved health outcomes in this population by having the potential to reduce morbidity and mortality in the long term.